The relationship between protein intake, gut microbiome, inflammaging and loss of mobility in older adults

This K01 application is for Dr. Samaneh Farsijani to establish a research career in Nutritional Epidemiology and
acquire skills to integrate omics (gut microbiome) and non-omics (dietary intake) data towards her long-term goal
in “Precision Nutrition” to develop age-specific dietary recommendations, replacing the current one-size-fits-all
approach, to promote healthy aging. The proposal is derived from the candidate’s extensive training in nutrition
and interdisciplinary research background in biology and epidemiology. The proposed training goals are directed
to advance candidate’s skills in 1) aging & nutritional epidemiology; 2) advanced biostatistics; 3) gut microbiome;
and 4) career development. Acquired skills will be applied toward the proposed scientific goal to determine the
relationships between protein intake, gut microbiome, inflammation, and mobility loss in older adults. Aging is
associated with inefficient utilization of dietary proteins, due to anabolic resistance, which potentially leads to
functional losses. Also, up to 50% of US older adults fail to meet the Recommended Dietary Allowance (RDA)
for protein (0.8 g/kg body weight/d). Therefore, a higher protein intake, above the RDA (1.0-1.2 g/kg/d), has been
suggested to compensate for changes in protein metabolism and to maintain muscle health in aging. However,
this strategy has not been incorporated into dietary guidelines due to inconclusive evidence from small and short-
term studies, which were unable to show the underlying mechanisms and causal relationships between protein
intake and mobility function in older adults. Gut dysbiosis (i.e., changes in gut microbiome) and inflammaging
(i.e., low-grade chronic inflammation in aging) have been linked to frailty in older adults. Since diet plays a key
role in shaping the gut microbiome and inflammation, it may be speculated that the effects of protein intake on
mobility function are mediated through alterations of dysbiosis and inflammaging. Our central hypotheses are:
i) high protein intake reduces the risk of mobility limitation by ameliorating inflammaging; ii) different protein
intake metrics are independently associated with gut microbiome and inflammaging; and iii) gut dysbiosis is
associated with mobility impairment in older adults. This proposal will leverage data from Health, Aging & Body
Composition (Health ABC), and Study of Muscle, Mobility & Aging (SOMMA) cohorts to address three Aims:
Aim 1: To simulate a pragmatic clinical trial using the Health ABC cohort to determine i) the effect of protein
intake on the risk of mobility limitation, and ii) its causal mediation by amelioration of inflammaging. Aim 2: a)
To characterize the associations between different metrics of protein intake (i.e., quantity, source and within-day
distribution pattern), gut microbiome composition, and fecal metabolites; and b) to determine the association
between gut dysbiosis and inflammaging in SOMMA. Aim 3: To determine the cross-sectional associations
between gut microbial composition and fecal metabolites with mobility (i.e., gait speed) in older adults from
SOMMA. This project will broaden our insights into the influence of protein intake, as a modifiable factor, on gut
microbiome, inflammaging, and muscle health in aging with the ultimate goal to drive age-specific dietary advice.

Public health relevance
PROJECT NARRATIVE (3 SENTENCES) We are in dire need to determine if higher protein intake, above the current recommendation (0.8/kg/d), can produce long-lasting beneficial effects to prevent age-related loss of muscle mass and function in older adults. This proposal determines the long-term effects of higher protein intake on prevention of age-related mobility disability; and identifies if dietary proteins enhance mobility function by improving the gut bacterial composition and reducing inflammation in the body. Findings from this K01 can drive age-specific dietary recommendations, replacing the current one-size-fits-all approach, to enhance mobility function in older adults by improving gut health and inflammation; and the acquired skills will help the Principal Investigator to integrate omics (gut microbiome) and non-omics (dietary intake) data towards a long-term career goal to develop “Precision Nutrition” strategies and age-specific dietary advice to promote healthy aging.